CENTERS FOR RADIOLOGICAL PHYSICS PROGRAM

Ensure national uniformity of review services provided by the six Centers for Radiological Physics (CRP) which operate in an assigned geographic region under individual contracts with NCI. Additional objectives are: to monitor centralized data collection; to provide summarized data; to coordinate CRP interregional calibrations and protocols; to prepare integrated reports on CRP activities; and to develop avenues for technology transfer to the medical physics community.